Summer Undergraduate Research Program (SURP) in Molecular and Developmental Neurobiology

Project Summary
The current proposal is to support a Summer Undergraduate Research Program (SURP) in Neuroscience
mentored by Rutgers University research faculty. The program has three primary goals: (1) To increase
student knowledge and appreciation of basic biological research by providing a closely-mentored, hands-on
research experience; (2) To increase student knowledge and interest in pursuing careers in research
through career development and educational activities; (3) To provide continued advice, support and
guidance to program alumni to facilitate post-program career planning and implementation. Twelve
undergraduates will be admitted to our program each year beginning 2018. Special consideration will be
given to students from economically and/or socially disadvantaged backgrounds including under-
represented minority applicants, first-generation college students, and those with limited research
experience or opportunities at their present colleges to generate a deep and diverse pool of potential future
scientists. The research component of the proposed SURP involves hands-on experimentation in labs with
active, nationally recognized and funded research programs in Neuroscience on the Piscataway and New
Brunswick campuses of Rutgers Universities. The infrastructure and general organization of the proposed
NIH Summer Research Experience program will be based on an existing program that has been in place for
21 years. Students will work on their own independent research projects involving cutting-edge molecular,
genetic and genomic approaches under the close guidance and supervision of mentors, postdocs or senior
graduate students in their host labs. The proposed SURP is designed to integrate student research
experiences and mentoring with career development and also includes training in research ethics. Student
activities include weekly meetings attended by scientists from our campus and from the professional
community to discuss their education and careers including traditional and non-traditional paths. Each year
students will present the results of their summer research projects in a symposium that is open to scientists
on campus and members of the general public. The mentors who will be supervising the students study
neurological and neurodegenerative disease including Alzheimer’s, Multiple Sclerosis, traumatic brain
injury, spinal cord injury, lysosomal disease, sensory loss, epilepsy, and stroke. The multidisciplinary
research focus of the faculty mentors on the cellular, molecular, and genetic processes underlying
developmental and degeneration of the nervous system has implications for the etiology, pathogenesis and
progression of neurological disorders.

Public health relevance
Project Narrative Studies on the development, regulation, and maintenance of neural circuits yield insights into mechanisms underlying neurological and neurodegenerative diseases. The multidisciplinary training efforts of our faculty working with undergraduate student participants will focus on neurological disorders including Alzheimers, Multiple Sclerosis, traumatic brain injury, spinal cord injury, lysosomal disease, sensory loss, epilepsy, and stroke which are of clear relevance to NINDS.